TO CONTINUE THE COLLECTION AND REPORTING OF CANCER STAGING DATA BY THE SEER REGISTRIES, THE NCI/DCCPS SEER PROGRAM REQUIRES ACCESS TO THE MOST CURRENT CANCER STAGING DATA.

Support to NCI TO CONTINUE THE COLLECTION AND REPORTING OF CANCER STAGING DATA BY THE SEER REGISTRIES, THE NCI/DCCPS SEER PROGRAM REQUIRES ACCESS TO THE MOST CURRENT CANCER STAGING DATA.